GABAPVp-originated neural circuits mediate metabolic benefits during cold exposure

PROJECT SUMMARY
Despite the tremendous efforts in obesity research, pharmacological interventions that solely suppress appetite
alone have proven largely ineffective in addressing this global health issue. Therefore, increasing energy
expenditure has emerged as an alternative means to combat the obesity epidemic. Emerging evidence suggests
that cold exposure is a promising approach to alleviate obesity and related metabolic disorders, but the
neurobiological mechanisms mediating cold response remain poorly understood. In my pilot studies, I
demonstrated that cold exposure evokes a profound activation of neurons in the posterior periventricular
hypothalamic nucleus (PVp), most of which are GABAergic. I further showed that activation of GABAergic
neurons in the PVp (GABAPVp neurons) increases both food intake and energy expenditure. Strikingly, repeated
activations of these GABAPVp neurons resulted in improved glucose tolerance and insulin sensitivity, despite the
fact that mice constantly ate more. Together, I developed a hypothesis that GABAPVp-originated neural circuits
mediate metabolic benefits during cold exposure. The K99 phase will focus on unravelling the physiological
relevance of cold-sensitive PVp neurons in energy and thermal homeostasis. I will use intersectional genetics to
dissect the functional relevance of different PVp subsets on energy and thermal regulations during cold
exposure. In addition, I will employ the GRIN lens calcium imaging system to monitor the response to cold
exposure and feeding in individual GABAPVp neurons. During the R00 phase, I will utilize the techniques and the
problem-solving experience I acquire from the K99 phase to identify the downstream targets that mediate the
effects of GABAPVp neurons and the cold-sensor. I will combine the Cre-loxP, Flpo-Frt strategies and retrograde
viral vectors to determine the contributions of the lateral periaqueductal gray (LPAG) and lateral parabrachial
nucleus (LPBN) to energy and thermal homeostasis during cold exposure. I will also assess the effects of Kcnk2
in GABAPVp neurons on cold-sensing as well as energy and thermal balance. The K99 phase will provide an ideal
training opportunity to equip me with essential techniques, knowledge, and problem-solving skills, which will
prepare me for the R00 phase of research and growing into an independent researcher focusing on neural
mechanisms of obesity and energy balance.

Public health relevance
PROJECT NARRATIVE The unprecedented prevalence of obesity and related metabolic diseases highlights the urgent need to develop novel therapeutic strategies. This proposal aims to unravel the role of cold-activated neurons in the posterior periventricular hypothalamic nucleus in regulating energy and thermal homeostasis, as well as identify the downstream mediators and potential cold sensors. By uncovering the complex neural mechanisms that contribute to the regulation of energy and thermal homeostasis, my research will provide necessary groundwork to facilitate development of new treatment strategies for obesity and associated metabolic disorders.